Meeting young people where they are: Using technology to promote resilience among child maltreatment victims

PROJECT SUMMARY/ABSTRACT
There are approximately four million referrals to child protective services (CPS) in the United States each year.
Children and youth who receive adequate support often experience fewer negative physical, mental, and social
health outcomes and are less likely to perpetrate violence in the future than their peers who received no or
inadequate support. Younger children tend to exhibit signs and symptoms that help others to identify their need
for intervention. However, young people are unlikely to discuss and report their experiences through traditional,
face-to-face interactions. Technology-facilitated communication (e.g., text, chat, social media) is the preferred
communication method for many young people. The candidate’s prior work demonstrated that many young
people share their child maltreatment experiences through social media and other technology-facilitated
platforms. Thus, technology-facilitated communication may be leveraged to support young people through their
help-seeking experience and connect them with appropriate resources. The objectives of this K01 are twofold:
1) This K01 will support the candidate to gain additional training required for an independent, interdisciplinary
research career developing and evaluating technology-based interventions that support young people while
seeking maltreatment-related resources and information. Working with a team of experts in the fields of
developmental psychology, child and adolescent health, bioethics (including online research and research with
vulnerable populations), computational analytics, and digital health communication, the candidate will gain 1a)
knowledge and expertise in research ethics related to technology and vulnerable populations, 1b) skills in
computational data analytics and visualization, and 1c) experience in developing and implementing health
communication interventions. 2) The research conducted through this K01 will build the empirical foundations
for future interventions by 2a) identifying the language used by young people to discuss their maltreatment
experiences (Aim 1), 2b) evaluating the feasibility of using technology to reach young people seeking
maltreatment-related information and support (Aim 2), and 2c) developing and piloting technology-facilitated
interventions that connect young people to appropriate resources (Aim 3). After completing the training and
research activities proposed in this K01, the candidate will be uniquely prepared to launch a career as an NIH-
funded researcher investigating novel approaches to preventing the negative health consequences of child
maltreatment.

Public health relevance
PROJECT NARRATIVE Experiencing child maltreatment is associated with poor physical, mental, social, and economic outcomes, which are often exacerbated by young people’s difficulties in sharing their experiences and accessing appropriate, supportive resources. This project will build the evidence base for interventions that reach maltreated young people through their preferred approaches, support them through their help-seeking efforts, and connect them with appropriate resources. Ultimately, this work may help young people develop resilience and avoid the harmful short- and long-term consequences of child maltreatment.